Identifying Neural Signatures of Racial Discrimination in Black individuals with a Multivariate Data Fusion Approach

Project Summary
The current proposal utilizes an innovative, multivariate data fusion approach that
combines ecological momentary assessment of racial discrimination (RD) and multimodal
human neuroimaging to characterize neural network alterations related to RD exposure
and mental coping in Black Americans. Racial discrimination (RD) is embedded in the daily
lives of Black Americans and consistently linked to brain health disparities. However, the neural
mechanisms through which RD—both exposure to RD and mental coping responses—increases
risk for these brain health disparities are unclear. Few studies have investigated relationships
between RD exposure and cognitive and emotional facets of response and variance in brain
networks. Further, extant research has used univariate methods and retrospective RD reports.
Ecological Momentary Assessment (EMA) is a direct, ecologically-valid way to assay RD
experiences and mental coping responses in real time. Multimodal, multivariate approaches such
as multiset canonical correlation analysis + joint-independent component analysis (mCCA + jICA)
with reference can incorporate EMA data with different neuroimaging methods in the same
analysis, permitting the identification of cross-modal neural network differences that distinguish
unique features of RD. This approach is ideal for capturing high-dimensional relationships
between RD exposure and emotional/cognitive coping responses, modeling variance likely to be
missed by unimodal techniques. As such, mCCA + jICA is a comprehensive data fusion
method that can be used to identify unique RD-related brain signatures. These biomarkers
may be used as targets for neuromodulation. Our objective is to use this data fusion approach,
merging EMA with several magnetic resonance imaging (MRI) modalities, including task-based
and resting-state functional MRI as well as structural MRI assessing features of white and gray
matter morphology (diffusion-weighted imaging, T1-weighted imaging) to investigate associations
between RD exposure and mental coping and structural and functional covariance in neural
networks. We will recruit 220 Black Americans from the metropolitan Atlanta, Georgia area. Given
that many participants will have experienced a range of other stressors, structural inequities, prior
trauma and post-trauma psychopathology, we will include these variables in analyses as
covariates; we will also examine interactions of RD with structural inequities/stressors in
secondary analyses. The findings of this study can provide reliable and valid RD biomarkers and
targets for neuromodulation. This may contribute significantly to our current understanding of how
RD gets “under the skin,” to affect brain networks and enhance risk for brain health disparities.

Public health relevance
Project Narrative Racial discrimination is a type of racism that impacts Black Americans and leads to health disparities. However, little is known about how racial discrimination affects brain networks, indirectly leading to these disparities. We will use a data fusion approach to assess how racial discrimination impacts brain networks in Black American men and women.